PHARMACOKINETIC /DYNAMIC STUDY OF HU ANTICD3 (HUM291) IN RENAL ALLOGRAFT

If the patient is discharged from the hospital before the 2nd or 3rd dose of HuM291 are administered we plan to admit the patient for a short stay to the GCRC to have the drug administered and blood samples drawn.